Repurposing of R-etodolac for Alzheimer's disease and related disorders

Repurposing of R-Etodolac for Alzheimer’s Disease and Related Disorders
Summary
The deposition of amyloid-β (Aβ) in cerebrovasculature can result in blood-brain barrier (BBB) dysfunction and
the development of cerebral amyloid angiopathy (CAA). CAA is a pathological feature that presents
concomitantly with Alzheimer’s disease (AD) at a high frequency, highlighting a potentially important role for
vascular Aβ in AD. Currently, no treatment is available to slow or hold the progression of CAA or AD. Recent in
vitro and in vivo findings from our laboratory demonstrated that treatment with etodolac, a non-steroidal anti-
inflammatory drug (NSAID) used to treat pain and arthritis, restored the BBB function and rectified Aβ toxic effects.
However, the long-term use of NSAIDs, especially in the elderly, is not recommended because of toxicities
resulting from cyclooxygenase (COX) inhibition. Etodolac is a racemic drug with the S-enantiomer responsible
for COX2 inhibition associated with adverse effects. R-etodolac, on the other hand, lacks the COX2-inhibitory
effect. Thus, R-etodolac has the potential advantage of avoidance of COX2 inhibitory adverse effects observed
with racemic etodolac. Preliminary in vitro data demonstrated that, like racemic etodolac, both enantiomers
upregulate tight and adherens junction proteins, which are essential for BBB integrity. However, only R-etodolac
upregulates β-catenin, which is required for full cellular control of endothelial permeability and junction
stabilization. Based on these findings, this proposal aims to delineate the COX2-independent effect of R-etodolac
on endothelium-BBB model integrity and function (R61 phase), and in vivo on BBB function, brain Aβ
accumulation and related pathology, and memory function (R33 phase). We hypothesize that R-etodolac
attenuates vascular Aβ pathogenesis by restoring the BBB function. In phase 1 (R61, Aim 1), we will investigate
and compare the in vitro potency of racemic, R- and S-enantiomers of etodolac to improve the function of a cell-
based endothelium-BBB model with Aβ pathology. Concentration-dependent studies will be performed to assess
the compounds' effects on the endothelium-BBB model permeability and Aβ clearance, RNA transcriptional
changes, and R-etodolac pharmacokinetics and brain disposition. In phase 2 (R33, Aim 2), we will investigate
the in vivo efficacy of orally administered R-etodolac to rectify BBB integrity, improve learning and memory and
reduce Aβ deposition and related pathology in a transgenic mouse model of CAA/AD. Following treatments,
mice will be assessed for cognitive performance using a battery of cognitive tasks, for alterations in BBB
permeability using gadolinium contrast agent magnetic resonance imaging (Gd-MRI), and for alterations in
biomarkers of Aβ-related pathology. Successful completion of the project will pave the way for the repurposing
of R-etodolac as a novel molecule to prevent and/or slow the progression of CAA and AD that can be rapidly
translated to the clinic. The results will have a significant positive impact as R-etodolac does not possess COX2-
mediated adverse effects making it safe to use for long term by the elderly.

Public health relevance
NARRATIVE Alzheimer’s disease (AD) and related disorders constitute a major public health problem. In addition to its health consequences, AD has been reported to triple the healthcare costs. Our preliminary and published studies demonstrated etodolac and its R-enantiomer have promising effects against CAA and AD. The proposed project will evaluate the repurposing of R-etodolac, which lacks the S-enantiomer reported side effects, and determine its efficacy in a CAA/AD mouse model. Findings could position the repurposing of R-etodolac as a potential preventive and/or treatment for AD and ADRD.